Training Grant on Genetic Aspects of Alcoholism

PROJECT SUMMARY: This application is a competing renewal for an Institutional Ruth
L. Kirschstein NRSA Training Grant on the "Genetic Aspects of Alcoholism." The
objective of this training program is to provide high level predoctoral and postdoctoral
research training on various aspects of the genetics of alcohol use disorder, and
mechanisms underlying high alcohol drinking behavior. The main focus of the research
training is on the genetic, biological and molecular basis of high alcohol-seeking and -
drinking behaviors. Major topics of research include neuronal mechanisms underlying
excessive alcohol-motivated responding; the genetics of alcohol preference in selectively
bred rodent lines; analysis of the extent that genetically-influenced biobehavioral factors
such as disinhibition, impulsivity and tolerance contribute to alcoholism risks in human
populations; neuropsycho-pharmacological and neuroimaging studies on alcohol craving
in humans and rodents; mechanisms and heritable risk factors that drive decision-
making. The rationale for the research training program is that we do not yet fully
understand how heritable factors influence alcohol drinking behavior. This is a very
important topic and the field needs highly trained research investigators proficient in the
newest behavioral neuroscience approaches. In addition, our program offers
translational research training, encompassing both human and animal studies. The
program is designed to give the trainee exposure to and participation in high-powered
research projects in which state-of-the-art methodologies are used. We expect to
support 7 predoctoral trainees (after their first 2 years of graduate study), and 3
postdoctoral trainees (usually with 0-2 years of post-graduate experience). We anticipate
supporting trainees for at least 3 years (some predoctoral trainees may take 1 or 2
additional years). RELEVANCE: There is convincing evidence that alcohol use disorder
runs in families and that family history represents a risk factor for elements that
predispose high alcohol drinking. Identifying the genes and neurobiological systems that
contribute to alcohol use and abuse would greatly contribute toward understanding and
treating alcohol use disorder.

Public health relevance
NARRATIVE: The objective of this program is to train individuals to study the genetic and neurobiological basis of high alcohol-seeking and drinking behaviors. This field of research is important for developing treatment strategies for both the prevention and treatment of alcohol use disorders.